Actions Of Endogenous And Exogenous Cannabinoids On Brai

The main psychoactive component of marijuana is known as delta9-tetrahydrocannabinol (THC). In addition, it has recently been discovered that endogenous substances are synthesized in the brain that can activate cannabinoid receptors, and these substances are referred to as endocannabinoids. All drugs, both natural and synthetic, that act at receptors for this substance are known collectively as cannabinoids (CBs). Cannabinoid drugs obtained by the smoking or ingestion of marijuana are used illicitly presumably because they are reinforcing or rewarding to humans. The objectives of this study are to gain knowledge about the underlying mechanisms through which cannabinoids alter brain cell function, and ultimately the mechanisms that produce the pleasurable effects of these drugs that sustain their illicit use. Cannabinoids act in discrete brain areas to produce their effects. The focus of this laboratory is to examine the effects of drugs of abuse on the electrical activity of individual nerve cells (neurons) and the ways in which these neurons communicate with each other via synaptic connections. Therefore, one of our goals is to identify specific electrically conducting ion channels whose activity is modified by CBs. To achieve these goals we will utilize rat brain slices acutely obtained from discrete brain areas, perform whole-cell electrophysiological recordings, and, using cellular anatomical techniques, morphologically reconstruct the neurons from which we record. In these ongoing studies we are examining the effects of cannabinoids on neurons and their connections in the ventral tegmental area (VTA). This brain area and its connections are strongly implicated in the reinforcing and rewarding actions of all abused drugs. We will also examine the effects of these drugs in the nucleus accumbens, a brain area that is also known to be involved in the rewarding effects of CBs. Cannabinoids are known to be abused and are self-administered by laboratory animals. However, their actions in the VTA have only been recently investigated. It is known that injection of CBs into anesthetized rats causes an increase in firing rate of neurons in the VTA, and that the activity of these cells is important in producing pleasurable sensations. However, the mechanism of this increase in firing is incompletely understood. Therefore, these studies will examine the mechanisms of action of cannabinoids on neurons in the VTA. This will allow greater understanding of the neural substrates that support the abuse of this class of drugs, as well as describe the basic mechanisms of drug abuse in general. It is hoped that these studies will produce knowledge that can be used to develop treatments for the abuse of CBs, and provide a greater understanding of the role of endocannabinoids in mediating reward. Brain slice preparations will be used in conjuction with confocal microscopy to answer questions regarding the synthesis and release of endocannabinoids in VTA and NAc neurons. Thus far we have demonstrated that blockade of a potassium ion channel (Sk) that normally keeps VTA dopamine neurons (DANs) quiescent, increases their level of spontaneous activity, and this results in endocannabinoid release. These endocannabinoids then appear to act on CB1 cannabinoid receptors in the VTA to inhibit both GABA and glutamate synaptic inputs to the DANs. Since the GABAergic inputs to these cells is derived from inputs from the nucleus accumbens, we believe we have identified a functional link between these two important mediators of drug action, and endocannabinoid function. These studies represent the first to demonstrate that both THC, and endocannabinoids can act upon these moilecular targets to modulate the activity of DANs in the VTA. As the next step in these ongoing studies, we have set up a confocal microscope equipped to perform calcium imaging in brain slices, and to further examine the role of endocannabinoids in regulating neurotransmitter release in dopamine-containing neurons (DANs) in the VTA. The basic strategy that will be used is to evoke the release of calcium from intracellular stores using the technique of flash photolysis, which causes the uncaging of a molecule such as phosphatidylinositol. We will then assess whether this rise in intracellular calcium can subsequently result in an increase in the release of endocannabinoid that will then inhibit the release of the inhibitory neurotransmitter GABA. The rise in intracellular calcium levels will be monitored using ratiometric calcium detection techniques and the level of calcium will be related to the degree of synaptic inhibition that can be reversed by cannabinoid receptor antagonist application. These studies will be the first to directly relate rises in intracellular calcium with the release of endocannabinoids in the mammalian CNS.[unreadable] Additional studies now under way are aimed at defining the effects of cannabinoids on selectively activated excitatory inputs to the VTA. These experiments are comparing properties of pedunculopontine (PPN) inputs to the VTA with those from the cerebral cortex with regard to presynaptic modulation and sensitivity to stiumuli known to produce synaptic plasticity.